EFFECTS OF DEHYDROEPIANDROSTERONE (DHEA) ON HUMAN HEMOSTASIS ON THROMBOSIS

To assess the effects of two weeks of oral Dehydroepiandrosterone therapy on multiple hemostatic variables, including direct measurement of fibrinolytic activity.